NOCTURNAL HYPOGLYCEMIA EFFECT ON SLEEP PATTERNS OF DIABETIC CHILDREN

Mild hypoglycemic impact on sleep patterns in type I diabetic children is being assessed by polysomonography. More recently we have examined the effect of sleep on counterregulatroy hormone responses to hypoglycemia.